Kinase regulation in cerebral ischemia

Project Summary
Cardiopulmonary arrest (CA) is a major cause of death/disability in the U.S. with poor prognosis and survival
rates. The current CA therapeutic challenges are physiologically complex because they involved hypoperfusion
[decreased cerebral blood flow, (CBF)], neuroinflammation, and mitochondrial dysfunction. Our long-term goal
is to identify these complex regulatory elements that ultimately control neuronal viability. In our pilot study, we
discovered that novel serum/glucocorticoid-regulated kinase 1 (SGK1) is highly expressed in brain NEURONS
that are susceptible to ischemia (e.g., hippocampus and cortex). Inhibition of SGK1 via GSK 650394 (specific
inhibitor) alleviated CA-induced hypoperfusion, neuroinflammation, mitochondrial deficits, neuronal cell death,
and learning/memory deficits; this suggests SGK1 may play a detrimental role during ischemia. The primary
goal of this proposal is to inhibit SGK1 and utilize pharmacological (specific SGK1 inhibitor) and cell type
(neuron)-specific genetic approaches (e.g., shRNA) in our well-established rodent models of CA to answer the
central hypothesis: SGK1 expression is enhanced after CA, which leads to hypoperfusion,
neuroinflammation, mitochondrial dysfunctional, and neurological deficits. In Aim 1, the role of SGK1 in
CA-induced hypoperfusion will be investigated. How SGK1 causes CA-induced hypoperfusion will be determined
via two-photon microscopy and laser speckle contrast imaging (Aim 1a and 1c). Furthermore, we will identify
potential vasoactive mediators that contribute to SGK1-mediated hypoperfusion using PCR, capillary-based
immunoassay, and ELISA (Aim 1b). In Aim 2, we will determine if SGK is responsible for neuroinflammation and
mitochondrial dysfunction after CA by exploring three objectives. First, how SGK1 affects microglia
activation/polarization and astrogliosis following CA, which will be investigated via brain histology and flow
cytometry (Aim 2a). Second, inhibition of SGK1 alleviated CA-induced neuroinflammation will be analyzed via
protein chip assay (Aim 2b). Third, the harmful effects of SGK1 on mitochondrial ion homeostasis and energetics
will be studied by Seahorse respirometry and microspectrofluorometry, respectively (Aim 2c and 2d). In Aim 3,
we will evaluate the therapeutic potential of the SGK1 inhibitor against CA-induced neuronal cell death and
neurological deficits. Utilizing brain histology (Cresyl violet and Fluoro-Jade C staining) (Aim 3a) and behavioral
trials (Y-maze and novel object recognition test) (Aim 3b), the role of SGK1 in neurological deficits will be
determined. Successful completion of the proposed study will reveal the fundamental roles of SGK1 in neuronal
survival/death in cerebral ischemia-related diseases. Since the FDA has approved over 46 kinase-related drugs
for the treatment of various diseases, our study will be promptly translated into human clinical trials for the
patients suffering from CA.

Public health relevance
Project Narrative Cardiac arrest is the most devastating disease in the United States affecting more than 550,000 people per year. Despite prompt emergency treatment and better resuscitation techniques, 70-90% of patients die from extensive brain injury, with only three to ten percent of patients able to resume their former lifestyles. Our goal is to understand the mechanisms of serum/glucocorticoid regulated kinases that cause brain injury after cardiac arrest, to lay the foundation for novel therapeutic interventions against cardiac arrest.